Communities Helping the Hearing of Infants by Reaching Parents: The CHHIRP Navigator Trial

PROJECT SUMMARY
As the most common neonatal sensory disorder in the United States, infant hearing loss has an incidence of
1.7 per 1000 births. The consequences of delayed diagnosis and failure to obtain timely intervention include
significant communication impairment and negative socioeconomic effects. The overall lifetime medical,
educational, and occupational costs due to deafness is estimated to be over $2.1 billion. Early detection of
hearing may prevent language development and learning disorders. National standards dictate that all infants
should be screened by 1 month of age, diagnosed by 3 months of age, and initiate treatment by 6 months of
age (1-3-6 rule) and no more than 10% of infants should be non-adherent to diagnosis within 3 months after
birth. In 2015, 59.4% of U.S. infants failed to obtain a diagnosis within 3 months after abnormal screening.
There is a need for the development and implementation of interventions that promote adherence to timely
diagnosis and treatment standards. Early infant hearing detection and intervention (EHDI) programs are
coordinated on a state level, and the diagnostic process is complex and difficult for parents to navigate.
Families of children with hearing loss report that they lack confidence and support in obtaining care for their
child. Patient navigator (PN) programs have improved adherence to recommended diagnostic testing in cancer
care after the detection of a screening abnormality, resulting in substantial healthcare system cost savings.
PNs are trained individuals who mitigate barriers to promote healthcare adherence by educating patients and
improving self-efficacy. We have recently demonstrated the PN efficacy to decrease non-adherence with infant
hearing diagnostic care; however, PN has yet to be tested in diverse communities or implemented into EHDI
programs, and there is a gap in this field regarding effectiveness and implementation research on interventions
to reduce non-adherence. The proposed research is a community-engaged, type 1 hybrid effectiveness-
implementation trial of a PN intervention aimed at decreasing infant hearing diagnosis non-adherence after
failed newborn hearing screening, delivered in state-funded EHDI clinics. Guided by our community advisory
board and partners, we aim to 1) to test the effectiveness of PN to decrease non-adherence to receipt of infant
hearing diagnosis within 3 months after birth using a stepped-wedge trial design, 2) investigate implementation
outcomes and factors influencing implementation, and 3) determine the cost-effectiveness of PN from the
perspective of third party payers. This study is significant because it aims to reduce non-adherence to timely
infant diagnostic hearing testing to prevent life-long negative consequences. This research is innovative in
testing an intervention not previously assessed in hearing healthcare within a state-funded EHDI program, and
in integrating implementation research and cost-effectiveness methods with our effectiveness aim. Our results
will impact the field by partnering with communities to inform the scale-up of this and other innovative patient
supportive interventions to create efficient and effective EHDI programs and maximize public health impact.

Public health relevance
PROJECT NARRATIVE Hearing loss is the most common sensory congenital disorder and this condition is diagnosable and treatable. Infants who are born with hearing loss must undergo several hearing tests to diagnose the condition, and many families are delayed in receiving this testing or never obtain the necessary testing and treatment. This study evaluates (1) whether patient navigation in state-funded clinics throughout Kentucky increases parents' follow- through with testing, (2) factors that promote or impede its delivery, and (3) cost-effectiveness of this approach. !